Surface Plasmon Resonance Instrumentation

PROJECT SUMMARY
Experimental techniques that enable quantitative interrogation of the interactions between
different biological molecules are critical to biomedical research. Such techniques provide
important data to understand the molecular basis of diverse diseases, develop new mechanistic
models, discover new drugs and therapies, and guide other experiments. Surface plasmon
resonance (SPR) has emerged as a trusted, robust, and versatile method to explore the
thermodynamics and kinetics of molecular binding events. For twenty years, SPR instrumentation
has been an important and integral part of the Biophysics Core on the University of Colorado
Anschutz Medical Campus (CU-AMC) and has been used to support a wide variety of NIH-funded
projects. However, after two decades the equipment has become unreliable, costly to maintain,
obsolete, and will soon no longer be repairable. We propose to purchase a new SPR instrument
to replace our current instrument, ensuring SPR continues as a critical part of our campus’
research infrastructure. The instrument will be housed in an established, well-managed, and
funded Biophysics Core facility that will allow it to be maintained and to be coupled with expertise.
This instrument will be used by researchers from multiple basic science and clinical departments
and will be a key part of training the next generation of biophysicists and biochemists.
Furthermore, compared to the old instrument, the new instrument’s enhanced capabilities will
allow for experiments to be conducted with much less material, with a greater variety of molecules,
and in a higher-throughput way with greater sensitivity.
Acquisition of this new instrument will have an immediate and lasting impact on NIH-funded
research in areas as diverse as infectious diseases, virology, cancer, RNA splicing, cellular
protein localization, gene regulation, immunology, and drug design. The benefits to these (and
other) research areas include time and material savings, faster data collection, greater sensitivity,
ability to collect data under more diverse conditions, better small molecule binding detection, and
enhanced training opportunities.

Public health relevance
PROJECT NARRATIVE Understanding the causes of disease and developing new drugs to combat those diseases requires that we explore the interactions that occur between different types of biological molecules. Surface plasmon resonance (SPR) is a powerful and versatile technique to study molecular interactions that diverse researchers on our campus have successfully used for decades. Now, we seek to replace our aged twenty-year-old SPR instrument with a new, more sensitive, more reliable, and more versatile system that will allow researchers of all types to perform a variety of measurements related to understanding human disease.